META - Mentor, Educate, Train, Advocate: Patient Oriented Researchers in Cardiometabolic Disease

PROJECT SUMMARY
Dr. Latha Palaniappan, MD, MS is a well-recognized clinical researcher with a long track record of funding,
expertise, and mentoring in patient-oriented research (POR) in cardiometabolic disease. As a newly-appointed
Professor of Medicine at Stanford University, her extensive clinical research and teaching experience will help
her mentor and train the next generation clinical and translational scientists in POR. Although Dr. Palaniappan
is currently the lead investigator of two NIH-funded clinical trials, she is seeking support to pursue novel
mechanistic research directions in cardiometabolic health, particularly in adults of normal weight with Type 2
diabetes, which affects over 3 million Americans and is associated with higher cardiovascular mortality. In
addition, this K24 proposal will leverage Dr. Palaniappan’s breadth of experience to provide an innovative and
dynamic setting to train mentees in POR. Her mentees can leverage the existing research platform available
through two large, randomized clinical trials (RCTs), namely STRONG-D (normal weight) and IMPACT
(overweight/obese), and an existing institutional biobank (Stanford GenePool). These biobanked samples will
provide the basis for her future research direction which will focus on mechanistic differences in cardiometabolic
health in three groups: normal-weight patients with diabetes (STRONG-D), overweight/obese (IMPACT)
individuals with diabetes, and normal weight normoglycemic individuals (Stanford GenePool). She will use
human induced pluripotent stem cells, metabolomics, and exosome profiling. The Specific Aims are as follows:
Aim 1: Characterize cardiometabolic health across the three groups (n=40 in each group). We hypothesize that
normal-weight people with diabetes (NWD) will be most cardiometabolically unhealthy followed by overweight/obese
PWDs, followed by normal-weight normoglycemia.
Aim 2: Investigate the functional differences in human induced pluripotent stem cells (iPSCs), specifically in
cardiomyocytes and endothelial cells across the three groups (n=3 in each group). We hypothesize that individuals
with normal weight diabetes will exhibit more dysfunction in cardiomyocytes (less cardiac contractility) and
endothelial cells (less nitric oxide output).
Aim 3: Examine metabolite profiles across the three groups (n=40 in each group). We hypothesize that NWDs will
have more hepatic gluconeogenesis metabolites than overweight or obese individuals with diabetes.
Aim 4: Evaluate and compare exosome profiles across the three groups (n=40 in each group). We hypothesize that
NWDs will express more anti-angiogenesis miRNAs (miR-320) than overweight/obese individuals with diabetes after
controlling for weight.
This proposal will identify new pathways for intervention to predict, prevent and treat mortality and morbidity in
normal weight diabetes.

Public health relevance
PROJECT NARRATIVE The training of the next generation of patient-oriented researchers (POR) is critical for the advancement of science and medicine in the United States. This K24 award proposal is based on Dr. Palaniappan’s plan to use human induced pluripotent stem cells, metabolomics and exosome profiling to model cardiometabolic disease, and aims to use this platform to offer mentorship, education, training, and advocacy for potential K23 awardees. The research aims in this application expand on the scope of two large randomized clinical trials conducted by Dr. Palaniappan which focus on cardiometabolic disease and will provide a variety of innovative POR training venues for her mentees.